Identifying the Genetic Etiology of Neuropathology for Alzheimer Disease and Related Dementias

PROJECT SUMMARY
Multiple population and community based studies conducted across the US, Europe, Japan, and Australia all
have repeatedly observed complex neuropathologic changes in individuals with a clinical diagnosis of
Alzheimer's disease (AD) dementia. Although usually including neuritic plaques (NP) and neurofibrillary
tangles (NFT), the regional levels and extent of distribution of these hallmark lesions are variable. Additionally,
more than half of individuals with AD dementia have other comorbid lesions in brain that when present in
isolation can be diagnostic of dementia—the AD-Related Dementias (ADRDs). These include cerebral amyloid
angiopathy (CAA), vascular brain injury (VBI), Lewy body disease (LBD), and hippocampal sclerosis of the
elderly (HS), among others. Indeed, individuals with a clinical diagnosis of AD dementia frequently show a
complex mix of AD lesions and comorbid lesions, making it unclear the extent to which each contributed to
cognitive decline and dementia in that person. We hypothesize that the mechanisms of injury and response to
injury that produce these different disease-specific brain lesions are influenced by differing genetic factors.
With few exceptions, genetic studies for AD have associated genetic variants with a clinical diagnosis of
AD dementia. The comorbid complexity described above is a serious limitation to interpreting these data. Are
the associations with AD dementia related to the hallmark lesions of AD (common assumption), the variably
present comorbid lesions, or both? Only two studies have attempted to address this limitation. As a core
analysis of the Alzheimer Disease Genetics Consortium (U01AG032984), our study of AD neuropathologic
changes was the larger of these studies with approximately 4900 brain autopsies. However, even this initial
study was limited by sample size, platform, and less sophisticated analysis tools.
To address these limitations and to advance our knowledge of the full spectrum of dementia
neuropathology, we propose a genomics study of hallmark AD lesions together with comorbid lesions
associated with ADRDs. This study will expand the sample size of neuropathology subjects, will expand efforts
to include next-generation sequence data, and will implement more advanced statistical techniques to better
understand the relationships between traits. When successfully completed, our results will point to novel,
relevant molecular contributors for each of the pathologic lesions of AD or ADRDs, either alone or in
combination. To accomplish these goals we propose four Specific Aims. SA1: Identify genetic variants
associated with hallmark AD lesions by whole genome sequencing and genome-wide genotyping; SA2: Identify
genetic variants associated with comorbid lesions commonly present in brains of older individuals; SA3:
Determine the inter-trait genetic landscape by assessing confounding and genetic correlations across traits;
and, SA4: Determine regional, cellular, and lesion distribution of protein products of selected genes identified in
SA1-2.

Public health relevance
PROJECT NARRATIVE Both population and community based studies around the world have shown that clinical diagnosis of Alzheimer disease (AD) dementia is frequently accompanied by varying neuropathologic changes. These changes include differing rates and extent of Alzheimer “hallmark” pathologic changes (neurofibrillary tangles and neuritic plaques) as well as other lesions commonly associated with AD-related dementias (ADRDs). These lesions include cerebral amyloid angiopathy, vascular brain injury, Lewy body disease, and hippocampal sclerosis of the elderly, among others. The complex mixtures of brain lesions are not well understood, and limit interpretation of genomic analyses of clinic-based datasets. To address these limitations, we propose here an analysis of the genomics of the neuropathology of AD and ADRDs. Analysis will include harmonization and analysis of over 7,500 neuropathology samples and genetic data. When successfully completed, our study will point to novel, relevant molecular contributors for each of the pathologic lesions of AD or ADRDs, either alone or in combination.